Contribution of parallel inputs to speed tuning in higher visual cortex

Abstract
To encode visual information about our surroundings, the visual system uses neurons that respond to features
of the visual world—light, color, contrast, movement, orientation, speed, direction, and more. At the earliest
stages (retina, thalamus) of the visual system, these features consist of relatively simple properties, such as
spatial or temporal modulation of light, that are encoded as parallel channels. At later stages (primary visual
cortex (V1), extrastriate regions), these simple properties are combined to represent more complex visual
features, such as orientation, direction, and speed. How cortical circuits combine parallel inputs of simple visual
features and transform them into new complex visual features is incompletely understood.
One transformation that is highly relevant to many species is the identification of the speed of visual motion. The
speed of an object by definition requires the processing of at least two inputs- its spatial location and its temporal
displacement. These parameters can be studied quantitatively by using drifting sinusoidal gratings that vary
systematically in spatial frequency (SF) and temporal frequency (TF). Each combination of SF (cycles/degree)
and TF (cycles/second) corresponds to a particular speed (TF/SF = speed, degrees/second). In the visual
system, there are neurons that respond best when objects are moving at a particular speed; in other words, they
are “speed tuned.” Some speed tuned neurons are thought to first emerge within V1. However, most are found
in higher visual areas dedicated to motion processing. One hypothesis is that speed tuning emerges through a
summation of offset SF and TF channels from V1 to higher visual areas. New transgenic and viral tools enabling
cell type specificity as well as a recently improved understanding of the mouse visual system now make this a
tractable hypothesis to test in mice. In mice, higher visual areas anterolateral (AL) and posteromedial (PM) are
selectively tuned to different SFs, TFs, and speeds. AL is tuned to coarse features and fast speeds, while PM is
tuned to fine features and slow speeds. Past studies have shown that AL and PM can inherit SF and TF tuning
preferences from V1, but it is not known if they also inherit speed tuning or how speed tuning emerges.
Preliminary data have also identified two cell populations in V1’s main thalamic input layer (layer 4) that are
differentially tuned to SFs and TFs. This proposal hypothesizes that these V1 layer 4 populations represent
parallel inputs that contribute differentially to the tuning of neurons in higher visual areas and the generation of
speed tuning. The aims will first describe the speed tuning properties of V1, AL, and PM neurons in a laminar
specific manner and evaluate the response properties of these layer 4 populations using awake in vivo
extracellular electrophysiology and 2-photon calcium imaging. Finally, the hypothesis will be directly tested by
selectively inactivating each layer 4 population and determining its effect on tuning in AL and PM. Together,
these studies will have significant implications for understanding mechanisms of speed tuning in cortex and how
complex sensory information is transformed across hierarchal cortical areas.

Public health relevance
Project Narrative The proposed research will investigate how parallel visual inputs carrying distinct information about an object’s spatial location and temporal displacement are combined across cortical layers and cell types to give rise to speed tuning (distance/time) in visual cortex. Results of this work will address questions about fundamental transformations of visual information that occur between cortical areas. Given that many principles of cortical computations are conserved across cortical regions and species, this research will contribute to a better understanding of the cortical circuitry underlying sensory processing and how this processing is altered in neuropsychiatric and visual system disorders.